New catalytic methods for the rapid synthesis of N-unprotected chiral aziridines and amines

Project Summary
Amines and their derivatives are ubiquitous substances since they are present in the overwhelming majority of
drug molecules, agrochemicals, functional materials as well as many compounds that are produced by living
organisms (i.e., natural products). Notably, there are, on average, 2.8 nitrogen atoms in each of the 200 best-
selling small molecule drugs and, of these drugs, 80% contain at least one N-heterocyclic fragment. It is also
estimated that 45% of drug candidates contain a chiral amine moiety. Not surprisingly, organic chemists invest
a considerable amount of effort devising better strategies for synthesis of amines that serve as key chemical
building blocks for the preparation of biologically active compounds, especially in medicinal chemistry. These
strategies may be used for both the early-stage functionalization of simple feedstock chemicals and the late-
stage functionalization of complex molecules. Together these approaches enable the exploration of new
chemical space for biological studies. Consequently, new and powerful synthetic strategies and methods for the
rapid and direct introduction of nitrogen into readily available and inexpensive precursors such as alkanes,
alkenes, arenes, heteroarenes are expected to have a far-reaching impact upon how organic synthesis,
medicinal chemistry, biochemistry and chemical biology are practiced. In particular, the introduction of
unprotected and/or functionalized nitrogen atoms under mild conditions will result in processes that are more
efficient and “greener” than currently used multi-step routes and ultimately will lead to the faster development of
new medicines.
During the course of the proposed project we will focus on the development of novel direct (i.e., non-catalytic)
olefin difunctionalization methods. In particular, we are evaluating the native reactivity of N-acyl-N-halo-O-
sulfonyl as well as N-acyl-N-halo-O-alkyl/silyl hydroxylamines with feedstock olefins to obtain structurally diverse
and multifunctional hydroxylamine derivatives in a single pot (i.e., halo-aminohydroxylation of alkenes). The
resulting compounds can serve as structurally complex and versatile electrophilic aminating agents that readily
form C-N bonds with a variety of substrates. For example, non-catalytic as well as metal-catalyzed intra- and
intermolecular processes will be explored that take advantage of both stoichiometrically and catalytically
generated electrophilic aminating agents (i.e., complexity-building transformations, such as in intramolecular
and/or intermolecular aliphatic and aromatic C-H amination reactions, olefin aziridinations as well 1,3-dipolar
cycloadditions). Thus, the direct synthesis of chiral secondary and tertiary amines from structurally simple
precursors will be achieved. The proposed regio- and stereoselective amination processes will be thoroughly
investigated to uncover and understand their mechanistic underpinnings. Emphasis will be given to the
development of reactions that can utilize abundant and inexpensive starting materials and convert these to
structurally complex/value added products under operationally simple and mild reaction conditions.

Public health relevance
Project Narrative This project will explore the direct preparation of structurally complex multifunctional hydroxylamines from unactivated olefins by using N-halogenated-N-acyl-O-alkyl/arylsulfonyl hydroxylamines as difunctionalization reagents. These hydroxylamines will be exploited in a variety of intricate transformations, such as in intramolecular and/or intermolecular aliphatic and aromatic C-H amination reactions, as well as direct and stereospecific olefin aziridinations. The resulting unprotected amine products are of utmost importance in the synthetic/medicinal chemistry communities and the new environmentally friendly chemical transformations (i.e., green chemistry) that emerge will expedite synthetic access to and reduce the production cost of highly functionalized nitrogen-containing materials that ultimately will lead to the faster development of new medicines.